Mechanisms of Developmental Plasticity in the Mammalian Olfactory System

Project Summary/Abstract.
In the mammalian nervous system, a heightened level of plasticity is observed during early postnatal
development that enables the neural circuit to change according to environmental stimuli. We have discovered
that the mammalian olfactory sensory neurons (OSNs) undergoes a developmental switch during a critical
period of development. OSNs born during the perinatal period exhibit high levels of plasticity, exuberant axon
growth, and can alter their innervation targets following prolonged odor stimulation. Neurons born after the
critical period no longer exhibit these characteristics. The objective of this application is to determine the
molecular control of the critical period in olfactory system development. In particular, we will study the role of
Fzd1, which have multiple functions in regulating cellular and developmental processes in neural and non-
neuronal tissues, in regulating the critical period. By combining genetic manipulation, transcriptome analyses,
protein interaction assays, imaging, and behavioral assays, we will determine the requirement of Fzd1 in
regulating developmental plasticity of the OSNs. We will further determine at the molecular level how Fzd1
interact with other partners to increase neuronal plasticity during early phase of development and how it
regulates a transcriptional program to close the critical period. These studies will provide mechanistic insights
into axon pathfinding during OSN development and during adult neurogenesis.

Public health relevance
Public Health Relevance. The establishment of precise neuronal connection during development is essential for the function of the nervous system. The ability of neurons to establish and change connections in response to environmental stimuli is essential for learning and adaption at the individual level. In the mammalian species, the olfactory system is the only nervous system that continuously regenerates. The olfactory sensory neurons are continuously born throughout the lifespan of the animal and the newly generate neurons project to precise brain targets. This study will determine the molecular mechanisms that control the plasticity of axon pathfinding during development and during regeneration in the mouse olfactory system. Knowledge gained from this study will provide essential insights into the developmental regulation of regenerating neurons and provide important information on how the critical window of neural development is controlled. This may lead to the reopening of the critical period and benefit regenerative medicine.